The 29th International Evoked Response Audiometry StudyGroup (IERASG)

Project Summary
We request in this proposal partial support to cover the expenses of the 29th meeting of the International Evoked
Response Audiometry Study Group (IERASG) 2025 conference, which will be held June 14-18, 2025, at the
University of Colorado’s Boulder campus. Consistent with the goals of the first IERASG meeting in 1970, this
biennial meeting aims to bring together experts in evoked auditory response research and clinical assessment
of infants through adults with hearing loss or other hearing disorders such as auditory processing disorder,
tinnitus and hyperacusis. Invited are scientists and trainees who design equipment, protocols, as well as the
development of clinical protocols that utilize evoked auditory responses for clinical populations including, but not
limited to, hearing loss, brain injury, attention deficits, and autism among individuals across the lifespan. The
reason this is called a ‘study group’ is because the primary focus is to foster a healthy environment to mentor
new researchers. Hence, students, postdoctoral fellows, and medical residents are welcomed and encouraged
to interact with the experts. This meeting builds on the prior IERASG meeting held in Cologne, Germany, in
2023, with ~200 participants from over 29 countries. A goal of the 2025 meeting will be to continue to facilitate
the free exchange of ideas between students and basic and clinical scientists and to provide a framework for
novel collaborative efforts to advance our clinical and scientific understanding of neural processes from the
cochlea to the auditory cortex, function, dysfunction, and repair. The theme of the 2025 IERASG meeting will
be Forging Frontiers in Evoked Response Potentials, highlighting our focus on the intersection between
researchers and clinicians. An essential goal of this meeting will be to increase the diversity of attendees and
presenters. In particular, we intend to target trainees, clinicians, and clinician-scientists by hosting multiple
workshops the day immediately before the formal IERASG 2025 meeting. The meeting will be held on the
University of Colorado Boulder campus, chosen because of its convenient location, allowing easy travel, idyllic
campus and surroundings, and very reasonable costs with on-campus housing and dining options adjacent to
the conference venue available for attendees. This conference supports the mission of NIDCD by providing an
interactive platform to share research, train students and junior researchers and foster collaboration between
clinicians, researchers, and engineers.

Public health relevance
Project Narrative The focus of the 29th meeting of the International Evoked Response Audiometry Study Group (IERASG) 2025 conference is to bring together emerging leaders, clinicians, and expert researchers to address the gaps in current practice and learn about innovative research. Advanced auditory evoked potentials are appealing because they do not require active subject participation to obtain information about the processing of sounds by the auditory system. Hence, they can be used across the lifespan and for speakers of different languages and those from whom a behavioral response would not be possible.